Genetics of IgA nephropathy by integrative network-based association studies

Abstract:
IgA Nephropathy is the most common form of primary glomerulonephritis and an important cause of kidney
failure worldwide. The affected individuals develop characteristic IgA1-containing antibody complexes that
deposit in the kidney, producing progressive renal injury. The disease is associated with a specific pathogenic
defect in the O-glycosylation of IgA1 that promotes formation of immune complexes. Similar to other immune-
mediated disorders, IgA nephropathy has a complex genetic architecture. In the prior funding period, we
completed a GWAS for IgA nephropathy (10,146 cases and 28,751 controls) and we identified 30 genome-
wide significant risk loci, explaining 11% of disease risk. We observed clear convergence of biological
candidate genes on a common set of cytokine ligand-receptor pairs involved in mucosal IgA responses,
including on targets of existing drugs. In a GWAS of 2,170 cases and 5,928 controls, we also defined novel
genome-wide significant loci for IgA vasculitis, a related childhood condition with kidney complications. We
further enhanced these efforts by studies of serum IgA (GWAS in 41,263 individuals) and galactose-deficient-
IgA1 levels (GWAS in 10,193 individuals). Mendelian randomization provided strong genetic support for the
causal role of these endophenotypes. The overall goal of this proposal is to leverage these findings to identify
causal genes underlying shared genetic susceptibility between these traits. In Aim 1, we plan to conduct multi-
phenotype mapping across all four traits to better define shared and trait-specific loci. Multiome single nuclei
sequencing will be used to generate high resolution regulatory maps of IgA+ cells for fine-mapping and
prioritization of candidate causal genes. In Aim 2, we will study the role of the prioritized genes in health and
disease by leveraging Pakistani Genomic Resource, the largest cohort of human knockouts (KOs), with
homozygous KOs for >5000 genes and heterozygous KOs for >18,000 genes. We will perform call-back
studies in selected consanguineous families to identify carriers of loss-of-function and gain-of-function variants
in the genes of interest, followed by clinical and detailed immunophenotyping studies. These efforts will be
complemented by targeted gene perturbation experiments in IgA1-producing cells. In Aim 3, we will perform
phenome-wide association studies, and correlate our new genetic findings with clinical features. Based on
these findings, we will formulate and validate an integrated genomic risk score for kidney disease progression
in two large prospective cohorts of IgA nephropathy and IgA vasculitis with nephritis. These studies are
expected to refine our proposed disease pathogenesis model, define new therapeutic targets, and accelerate
clinical translation of our genetic findings.

Public health relevance
Narrative: This competitive renewal application aims to define genetic mechanisms underlying IgA nephropathy and IgA vasculitis with nephritis, two related conditions that contribute to kidney failure worldwide. The proposal integrates multi-phenotype genome-wide association studies, epigenetic analysis of IgA+ cells, focused gene perturbation experiments in IgA+ cells, studies of human knockouts in the Pakistan Genomic Resource, and clinical studies in prospective cohorts. These studies aim to identify new targets for therapeutic interventions.